Epigenetic and cellular markers of stress sensitization by early life stress in mice

PROJECT SUMMARY / ABSTRACT Early life stress (ELS) is one of the strongest lifetime risk factors for developing depression and other psychiatric disorders, particularly after facing additional stressful events in adulthood. However, relatively little is known about how the developing brain encodes experience of ELS to increase sensitivity to additional stress. To address this, I have established a translationally relevant “two-hit” mouse model of early life and adult stress, wherein stress during a specific postnatal sensitive window increases the likelihood that stress in adulthood will lead to depressive-like behaviors. This proposal will examine whether changes in transcription, epigenetic regulation, and cellular microcircuit reactivation are induced by ELS experience, and whether these changes directly contribute to stress-sensitized depression-like behaviors. This Pathway to Independence Award will provide the opportunity to build on my expertise in transcriptional and epigenetic consequences of early life experience while simultaneously developing my training and proficiency in bioinformatic analyses and approaches to increase cellular specificity. In the mentored (K99) portion of this award, I will focus primarily on characterizing the mechanisms that may contribute to stress sensitization. Under the mentorship of Dr. Eric Nestler and Dr. Panos Roussos at the Icahn School of Medicine at Mount Sinai in New York, I will investigate changes in transcription and “priming” of the epigenetic landscape using a variety of cutting-edge techniques including RNA sequencing, chromatin immunoprecipitation, and ATAC-sequencing. With added mentorship from Dr. Christine Denny at Columbia University, I will ask whether cells in mesocorticolimbic reward-related brain regions activated by ELS are reactivated by adult stress, using activity dependent transgenic mice (ArcCreERT2). I will then combine these approaches using a novel transgenic cross (ArcCreERT2 x R26-CAG- LSL-Sun1-sfGFP-myc) to examine, for the first time, changes in epigenetic priming specifically within nuclei isolated from ELS-activated cells. These experiments will ideally prepare me to functionally interrogate these mechanisms during the independent (R00) portion of this award. My independent laboratory will use pharmacogenetic inhibition to assess the necessity of cells initially activated by ELS for subsequent stress sensitization and depression-like behavior. In addition, I will use CRISPR constructs to knock out Setd7, an enzyme that establishes epigenetic priming by H3K4me1, and test the functional relevance of this mark for the stress sensitization effects of ELS. In sum, the research proposed in this Pathway to Independence Award will reveal both separate and potentially interactive molecular and cellular mechanisms of long-lasting ELS-induced stress sensitization. More broadly, the additional training afforded by this award will ideally prepare me to launch an independent research program evaluating multiple levels (epigenomic, cellular/microcircuit, behavioral) at which ELS leads to lifelong sensitivity to additional stress and enhanced vulnerability to depression and psychiatric disease.

Public health relevance
PROJECT NARRATIVE Early life stress heightens sensitivity to additional stress later in life, and is one of the strongest risk factors for developing depression and other psychiatric disorders. This proposal tests the hypothesis that early life stress primes the brain's reward circuitry to respond to additional stress via epigenetic and cellular mechanisms. This work will contribute to a novel understanding of depression vulnerability and will inform new therapeutic targets.